New Technologies for detecting extracellular fluxes

Abstract:
The goal of this Focused Technology and Development grant is to repurpose intracellular
fluorescent ion and metabolite sensors to detect extracellular fluxes. The three orthogonal
approaches directly target the cell’s glycocalyx: the nanometer thick, sugar‐coating where ion
and metabolite concentrations vary greatly during ion channel and membrane transporter
activity. Aim 1 describes an approach to attach any fluorescent protein sensor to cells
metabolically-labeled with an unnatural azidosugar. Aim 2 is a non-genetic approach that
labels all mammalian cells—including human cells—with both small molecule and protein
fluorescent sensors. Aim 3 is a chemical genetic approach to achieve cell-type-specific labeling
with small molecule and protein fluorescent sensors. Completion of the aims will convert these
working prototypes that utilize three major classes of fluorescent sensors (small molecule,
protein, and FRET) into technologies that enable the visualization of ions and metabolites at the
surface of a primary cells, tissues, and potentially in living animals.

Public health relevance
Project Narrative: The orchestrated release of ions and metabolites from cells and tissues is essential for neuronal excitability, cardiac rhythmicity, and muscle contraction. Accordingly, asynchronous and dysregulated release of ions and metabolites is the underlying cause of most human disease. The development of technologies that enable the spatiotemporal visualization of extracellular ion and metabolites fluxes from cells and tissues will allow researchers and clinicians to understand how these integrated electrical signals regulate brain, muscle, and heart function in healthy and diseased individuals.